A Widefield, Handheld OCT system for Patients who are Unable to Cooperate

ABSTRACT
In adults and older children, Optical Coherence Tomography (OCT) is the gold standard for diagnosis and
management of retinal diseases and systemic disease effects. Most clinical OCT systems are large, tabletop
devices that require a compliant subject, capable of positioning in a chin rest and fixating on a target. This
typically excludes infants, young children and patients who are unable to cooperate, from OCT imaging. These
patients have one of the greatest needs for OCT imaging due to their inability to communicate about disturbance
or loss of vision before critical stages of disease development or irrecoverable vision loss occurs. One group in
particular are infants at risk for retinopathy of prematurity (ROP) who make up 1.4% of the newborn population.
The use of handheld OCT (HH-OCT) systems for point of care imaging has led to significant insights into the
development of ROP. However, the clinical adoption of HH-OCT has been limited due to the slow speed, size,
and weight of current commercial HH-OCT systems and their limited field of view. While the 40° FOV of most
handheld systems is useful for macular imaging, it is insufficient for imaging of the peripheral retina where many
pediatric retinal diseases, especially ROP, occur. The overall premise of this proposal is that the development of
a highspeed, lightweight, widefield, handheld OCT system will significantly improve the diagnostic utility of HH-
OCT for assessment of retinal diseases including those involving the peripheral retina, such as ROP, in I/YC/UC
patients. This development will ultimately improve access to care for these patients and reduce the cost of care
for these patients.
Under NIH SBIR Phase I support (R43-EY033604) Theia Imaging developed the T1-W (widefield) system, a
light weight, high speed, contact HH-OCT system with a 110° FOV. The system operates at 300 kHz (9x faster
than any commercial handheld), its handpiece weighs 325g, and does not require mydriasis for imaging. Imaging
of an adult volunteer shows that the system provides excellent visualization of retinal structures in both the
macula and the periphery and en-face projections of retinal vessels demonstrate the ability of the system to
image most of zone II in a single acquisition. Under ongoing NIH support (R44-EY032394), Theia is developing
and pursuing regulatory clearance for 300 kHz non-contact OCT system. Instead of developing, pursuing
regulatory clearance for, and marketing a separate widefield device with the proposed modifications, we
will merge the non-contact and widefield systems into the T2-platform. The T2-platform costs of the T2-
core, a 300 kHz OCT engine with a modular scan head that accepts a variety of OCT lens bores including non-
contact and widefield bores. We believe that the flexibility and cost reduction provided by a modular
platform will dramatically improve access to OCT imaging for I/YC/UC patients, as one device can
provide imaging for the wide variety of pathologies that affect this underserved patient population.

Public health relevance
NARRATIVE Handheld OCT can be used to screen for and diagnose eye disease in infants, young children and many patients in intensive care or with certain disabilities, who are unable to cooperate for conventional tabletop imaging and are unable to communicate about loss or disturbance of vision, making it difficult to diagnosis vision- threatening diseases before irrevocable vision loss occurs. While the field of view of most non-contact handheld systems is useful for macular imaging, it is insufficient for imaging of the peripheral retina where many pediatric retinal diseases occur. To provide better access to OCT imaging for this underserved patient population, Theia Imaging is pursuing commercialization of a modular, high-speed, portable, user-friendly, hand-held OCT system that supports traditional non-contact OCT and widefield contact OCT.